Tryptophan metabolism and its role in fibroid pathogenesis

Abstract
In the course of our profiling for non-coding RNAs in fibroids we discovered highly aberrant overexpression of
Tryptophan 2,3 dioxygenase (TDO2) and Indoleamine 2,3-dioxygenase (IDO1) in fibroids. We confirmed this
finding by both qRT-PCR and Western blot analysis, and found a consistently elevated expression of TDO2 and
more variable overexpression of IDO1 in our tissue specimens. The increment in TDO2 expression in fibroids
was higher as compared to IDO1, and the expression of IDO2 was barely detected. Relevant to the pathogenesis
of fibroids was that the increment in TDO2 but not IDO1 was race dependent, with the increment being
significantly higher in African Americans as compared with Caucasians. Furthermore, the expression of TDO2
was significantly increased in MED12 mutation bearing leiomyomas, and its inhibition by pharmacologic blockade
in vitro led to decreased proliferation and expression of genes related to extracellular matrix, inflammation and
cell growth in leiomyoma smooth muscle cells (LSMC) spheroids. Aberrant expression of these enzymes in
fibroids resulted in increased levels of kynurenine (Kyn), a metabolic byproduct of tryptophan degradation and a
known endogenous ligand for Aryl hydrocarbon receptor (AhR). Based on this preliminary data we hypothesized
that dysregulation of Trp metabolism as characterized by marked overexpression of TDO2 is
fundamental to the pathogenesis of fibroids and correction of Trp metabolic dysregulation by inhibition
of TDO2 and normalization of kynurenine levels will inhibit fibroid growth and progression and
potentially tumor establishment. We propose to this hypothesis in 3 aims. In aim1 we will characterize Trp
metabolism in myometrium and fibroid tumors and explants, and determine the mechanism(s) underlying the
marked overexpression of TDO2 in fibroids using an in vitro approach. In Aim 2 we will examine the impact of
kynurenine and its activation of AhR on downstream genes regulating extracellular matrix (ECM), inflammation
and cell proliferation. Aim 3 is designed to determine the utility of a pharmacological inhibitor of TDO2 and with
lentivirus bearing shRNA to knock down TDO2 on fibroid establishment and progression in in vivo mouse models
of fibroids. This novel metabolic mechanism for fibroid pathogenesis has great translational significance as it
opens the way for novel therapies aimed at correction of tryptophan metabolism in fibroids.

Public health relevance
Narrative: The goal of this project is to determine how aberrant metabolism of tryptophan by fibroid tumors contributes to their growth and test novel therapies aimed at normalizing tryptophan metabolism for treatment of fibroids